Cancer Control and Population Science (CCPS)

PROJECT SUMMARY/ABSTRACT (CANCER CONTROL AND POPULATION SCIENCES)
The Cancer Control and Population Sciences (CCPS) Program is a realigned, unified program of the former
Cancer Epidemiology and Prevention and Health Behavior and Outcomes programs. CCPS members pursue
research in epidemiology, prevention and risk reduction, behavioral interventions, cancer care delivery, and
methods development, along with implementation science and policy research. The program is comprised of
72 members from 22 different departments and six schools with total annual direct research support of $17.7
million of which $12.7 million (72%) is from the NCI. Members are highly productive with 1,407 publications
during the project period (19.5% inter-programmatic, 26.3% intra-programmatic), and 1,272 participants were
enrolled in clinical trials. CCPS’s aims and strengths are closely aligned with the Rogel Cancer Center’s broad-
based themes, strategic vision, and mission via the program’s focus on team science, its commitment to
understanding cancer etiology, improving primary prevention and early detection strategies, and improving
cancer care delivery. The CCPS program has three main specific aims: 1) Identify key environmental, lifestyle,
genetic, and socio-structural targets for cancer prevention, risk reduction, improved detection, and better
outcomes; 2) Develop, test, and deploy innovative strategies to reduce the burden of cancer; and 3) Create
and apply novel scientific approaches to cancer control and population science research across the continuum.